Novel Mechanisms of Protein Homeostasis by the Molecular Chaperone DnaK

PROJECT SUMMARY
Proteins carry out almost all functions in all living cells. At the same time, cells must
coordinate protein synthesis with folding capacity to avoid misfolding and the
accumulation of highly toxic protein aggregates. Critically, chaperones enable most
proteins to adopt conformations required for essential biological activities. In bacteria,
the chaperone trigger factor (TF), which is as abundant as ribosomes, had long been
thought responsible for cotranslational protein folding when nutrients are plentiful.
However, we have now identified cytoplasmic Mg2+ starvation as an infection-relevant
stress condition in which the facultative intracellular pathogen Salmonella enterica
serovar Typhimurium requires Hsp70 chaperone DnaK instead of TF. Surprisingly,
DnaK directly decreases protein synthesis, thus conferring survival against cytoplasmic
Mg2+ starvation. This is the first example of DnaK performing protein homeostasis
activities independently of its J-domain cochaperones and nucleotide exchange factor.
We now propose to combine genetic, biochemical, and biophysical approaches to
determine how DnaK decreases protein synthesis, in course solving the structure of
DnaK-bound ribosomes harvested during cytoplasmic Mg2+ starvation. We will use
selective ribosome profiling to identify nascent polypeptides associated with DnaK
versus TF during cytoplasmic Mg2+ starvation and abundance. We will also interrogate
DnaK binding to the ribosome as necessary for bacterial resistance to proline-rich
antimicrobial peptides that attack the translation machinery and for survival against
cytoplasmic Mg2+ starvation and inside murine macrophages. The proposed
experiments will provide fundamental tools and knowledge to solve how slower
protein synthesis enables bacterial survival during infection. Moreover, results will
apply broadly to diverse microbes as this physiologically important chaperone is
widely distributed, shares high amino acid sequence identity across species, and is
required for virulence by multiple pathogens.

Public health relevance
PROJECT NARRATIVE We will investigate the mechanisms that control novel and essential biochemical activities carried out independently by the widely distributed and highly conserved Hsp70 chaperone DnaK and broadly relevant to diverse species. We will determine how DnaK reduces protein synthesis, folds proteins cotranslationally, and confers resistance to antimicrobial peptides that target the protein synthesis machinery and survival inside murine macrophages. This project takes advantage of our discoveries that DnaK reduces protein synthesis and is essential for bacterial survival against cytoplasmic Mg2+ starvation as well as our track record of solving fundamental biological questions in bacterial physiology and protein homeostasis.